Paradigm-changing, versatile, scalable and cost-effective technology for monthly injections of peptide drugs

PROJECT SUMMARY/ABSTRACT
Delivery of peptide drugs via non-invasive routes results in poor bioavailability and short plasma half-lives, hence
most are delivered by injections or implants. While conjugation/modification and microencapsulation of peptide
drugs in polymers have been highly successful, the success of peptide modification is limited by weekly
injections, the need for new active pharmaceutical ingredients (APIs) for each peptide, and inconsistent blood
levels causing side effects. By contrast, microencapsulation of peptides in polymers (i.e., poly(lactic-co-glycolic
acid, PLGA) has advantages of much longer intervals between injections (>weeks to months) and use of existing
APIs, thus reducing regulatory obstacles. However, current microsphere encapsulation strategies suffer from
lack of terminal sterilization, poor yields, problematic scale-up, residual organic solvent levels that limit storage
stability of the final products and non-zero-order release. New and improved delivery strategies are critically
needed to accelerate development and utilization of peptide drugs. Here, we propose to develop a cost-effective,
extremely simple, efficient, and generalizable water-based PLGA microsphere encapsulation technology for
peptides. This proposal will focus on formulation and optimization of sterile remote-loading microspheres for
constant delivery of commercial peptide drugs. These formulations will be tested for their pharmacokinetics after
single monthly injections vs. monthly commercial depots or daily injections of free peptide.

Public health relevance
PROJECT NARRATIVE The proposed research is of high relevance to public health as these studies will generate new fundamental knowledge in drug delivery by addressing the current limitations in drug delivery systems for peptide therapeutics. The proposed studies will result in lead sterile formulations that provides 1-month constant release of commercial peptide drugs based on an improved, extremely simple, efficient, scalable, cost-effective and generalizable water-based method for encapsulating peptides in biodegradable and biocompatible polymers.